Core C Community Engagement (CEC)

COMMUNITY ENGAGEMENT CORE (CEC)
Project Summary
The overall goal of the CEC is to actively engage residents and other stakeholders of the affected area
in education, research, and prevention and/or intervention to reduce or mitigate the impact of
hazardous substance exposure on chronic lung disease. The CEC includes a multidisciplinary team with
expertise in health disparities, community-engaged research, health education and promotion, and preventive
medicine. Guided by the principles of Community-Based Participatory Research (CBPR), the CEC will focus on
three specific aims: (1) to develop and implement an infrastructure for sustainable bi-directional communication
between residents of the affected area and UAB to build capacity for collaborative endeavors to address
environmental health issues; (2) to identify and develop tools and resources to assist communities impacted by
hazardous substances to address community-driven priorities to reduce exposure and protect health; and (3)
to implement evidence-based prevention/intervention activities to reduce exposure and protect the health of
residents impacted by hazardous substances. Working hand-in-hand with our Administration and Research
Translation Core, five research project teams and other cores, the CEC will serve a vital role in our Center's
research activities by helping to build trust and facilitate bi-directional co communication between members of
the community and the research team. The CEC will also provide opportunities for community members to
increase their knowledge about environmental health issues, learn about prevention and remediation strategies
to reduce exposure to airborne heavy metals, and increase community capacity to support collaborative
partnerships to address environmental health issues in their community. Over the 5 year project period, we will
construct and maintain an academic-community partnership infrastructure to support the long-term
sustainability of collaborations to improve community health and well-being and increase community resilience
to exposure to environmental hazards. In addition, we will design, deliver, and evaluate the effectiveness of a
wide range of community-engaged activities that seek to increase community members' health literacy, social
cohesion, self-efficacy for reducing risk of airborne heavy metal exposure, and knowledge about research
findings originating from our center.

Public health relevance
COMMUNITY ENGAGEMENT CORE (CEC) Project Narrative Communities proximate to sources of environmental contamination are adversely affected both by ongoing exposure and resulting health issues. Most often, these communities are also economically disadvantaged and lack the resources and capacity needed to overcome the impact of hazardous substance exposure. As such, the Community Engagement Core (CEC) will facilitate the development and maintenance of an infrastructure to support culturally-appropriate remediation of risks and/or complications of chronic lung diseases and resilience in communities impacted by hazardous substances.